Administrative Core

SUMMARY FOR ADMINISTRATIVE CORE
The Administrative Core will provide leadership, cohesion and logistics for the entire Yale ADRC to achieve its
goal of understanding the cellular basis of Alzheimer’s disease and translating this knowledge into effective
therapy. The Administrative Core will emphasize the use of emerging stem cell, imaging, fluid biomarker and
omic methodologies for translational science. A particular emphasis will be to define the variation in cellular
mechanisms across populations. The Yale ADRC will also strive to develop the careers of young Alzheimer’s
researchers of diverse background and to share Biospecimens and clinical data with Alzheimer and Aging
researchers at Yale and within NIA-sponsored networks. The Administrative Core will organize regular
meetings amongst Core leaders and with External and Internal Advisory committees. The Internal Advisory
Board will contribute general advice, career mentoring as well as evaluating Development Project proposals.
The Development Projects will support innovative Alzheimer’s disease research and will be administered by
the Core with the dual goal of pushing the boundaries of Alzheimer research and aiding the development of
New Investigator careers.